Effect of Air Pollution on the Immune Response to Respiratory Viral Infection in Adults

This proposed Mentored Patient-Oriented Research Career Development Award will support Dr. Croft's
advancement as a physician-researcher studying the effects of air pollution on the immune response to
respiratory viral infection (RVI). Specifically, Dr. Croft's proposed study provides an opportunity for mentored
development in advanced environmental epidemiology approaches, exposure assessment, immune system
transcriptomics, and research team management. RVIs are a serious cause of morbidity and mortality in
adults. PM2.5 and combustion related air pollution (black carbon: a marker of traffic pollution) have been linked
to an increased rate of hospitalizations for RVI. However, the immune mechanisms by which air pollution may
enhance susceptibility to severe RVIs (i.e. requiring hospitalization) in adults remains unclear. Dr. Croft's
overarching hypothesis is that short-term exposure to ambient air pollution increases the risk of a severe
documented respiratory viral infection in adults, by disrupting key gene pathways (e.g. NF-κB and IFN-γ) within
the innate immune response. To test this hypothesis, Dr. Croft will enroll patients hospitalized with rigorously
adjudicated, microbiologically proven RVI from an active R01 study on improved diagnostics for respiratory
infection. In this population of patients with RVI, he will then lead analyses to explore whether short-term
increases in multiple air pollutant and source-specific pollutant concentrations are associated with an increased
rate of hospitalization for specific RVIs (e.g. influenza or respiratory syncytial virus). In the same population of
patients, he will determine whether these pollutant exposures are associated with activation or suppression of
key innate immune pathways. Specifically, using a population of patients with clinically adjudicated diagnoses
of RVI, his study will use a case-crossover design to estimate the rate of RVI hospitalizations associated with
acute increases in the concentration of particulate and gaseous pollutants in the prior 28 days (Aim 1). Patients
with confirmed infection will undergo RNA transcriptional profiling of peripheral blood, allowing Dr. Croft to also
examine the association between the same short-term increases in pollutant concentrations and gene
expression within the innate immune system (Aim 2). In both aims, we will determine whether this response
may be sex-specific, race or ethnicity specific or unique in patients with COPD or asthma. This study may
immediately benefit the clinical counseling of patients with exposure to air pollution and may also help guide
future air quality policies to minimize the risk to populations vulnerable to RVI. Finally, the study results will
provide valuable data upon which to base a future prospective study of the effects of air pollution on respiratory
infection and innate immunity. His mentors include experts in environmental epidemiology (David Rich, ScD),
virology (Ann Falsey, MD) and transcriptomics (Thomas Mariani, PhD). Dr. Croft's highly productive mentor
team, including multiple content specific mentors, will help support his development into an independent
investigator pursuing clinical research on the respiratory health effects of inhaled toxins.

Public health relevance
Respiratory viral infections are an important cause of hospitalization and death in adults, and we are concerned that exposure to outdoor air pollution may reduce the body's ability to fight infection. This epidemiology study will examine the association between short-term exposure to outdoor air pollution concentrations and the immune system response to respiratory viral infection, in a population of adult patients hospitalized with severe respiratory viral infections. By studying this link between air pollution and respiratory viral infection, we can learn how to better counsel our patients to avoid specific pollutants in the short term, so as to protect them against severe respiratory infection, while we contribute to decisions on air quality regulations.